Developing a predictive risk score for pre-diabetes in youth.

PROJECT SUMMARY
The prevalence of impaired glucose tolerance (IGT) and youth onset type 2 diabetes (YT2D) is increasing. IGT
in adolescence is an indicator of increased risk for YT2D. Compared to adults, YT2D is associated with high
therapeutic failure rates, decreased response to insulin sensitizers, and rapid progression to diabetes-related
complications which suggests a more severe disease process in children. Therefore, identifying children at risk
for developing IGT/YT2D and intervening prior to disease onset is critical. Offspring of mothers with
hyperglycemia in pregnancy have a greater risk of developing obesity, insulin resistance, and type 2
diabetes. Therefore, utilizing family history, maternal clinical factors, and newborn labs could be helpful in
developing a predictive risk score for childhood IGT/YT2D. Epigenetic changes in offspring cord blood may be
associated with metabolic changes in early childhood. In this innovative study we hypothesize that using
offspring cord blood methylation (cbDNAm) will improve the precision of a predictive risk score. To explore this
hypothesis, I will use the well-characterized cohort of mother-offspring pairs from the large, multiethnic
Hyperglycemia and Adverse Pregnancy Outcome Study (HAPO) and its Follow-Up Study (HAPO FUS). Our
aims are to 1) develop an early predictive risk score utilizing clinical factors known at birth, 2) refine the early
life predictive risk score using cord blood biomarkers (c-peptide and methylation) and 3) recruit youth with IGT
to phenotype and follow longitudinally to characterize those that progress to YT2D. Analyses will use the
following statistical approaches: multiple logistic regression, least absolute shrinkage and selection operator
(LASSO) regression. Conducting this study will directly address my career development goals to 1) Gain
expertise in YT2D risk factors and epigenetic associations; 2) Develop skills in innovative statistical methods
and approaches to disease prediction modeling; 3) Develop clinical research skills and a cohort of children with
IGT to study longitudinally that will aid me in succeeding as an independent investigator. This study is the first
step in identifying early markers of youth at risk for T2D with the goal of evaluating other biomarkers, such as
hormones and genetics, to ultimately propose an R01 to refine and validate the predictive risk score. I will thus
achieve my career goal to identify those at risk for developing YT2D and will then be able to focus on
preventive interventions to decrease morbidity and mortality.

Public health relevance
PROJECT NARRATIVE Youth onset type 2 diabetes (YT2D) is associated with rapid progression to diabetes-related complications suggesting a more aggressive disease process in children. The medications that are available to treat YT2D in children are limited reducing the ability to improve health outcomes. The objective of this study is to develop an early life prediction risk score for impaired glucose tolerance/YT2D to ultimately implement targeted interventions that will result in decrease morbidity and mortality from YT2D.